TREATMENT OF MEDICATION RESISTANT TREMOR WITH THALMUS STIMULATION

This study is designed to determine the efficacy, safety, and reliability of chronic thalamic stimulation treatment of disabling tremor due to Parkinson's Disease (PD) and disabling Essential Tremor (ET). Also, to determine the acute effects of thalamic stimulation on autonomic function. We will continue to follow patients' progress. The Medtronic stimulator has been FDA approved for bilatoral implantation.